SINGLE DOSE OPEN LABEL STUDY OF PIPERACILLIN AND TAZOBACTAM CONCENTRATIONS

This is an open label, single dose, tissue distribution study assessing the penetration of the combination of piperacillin and tazobactam (in an 8:1 ra o) into bone at one hour after initiation of a 30 minute intravenous infusion patients undergoing elective total hip replacement.